Build-up of beta-amyloid in the brain in Parkinson's disease-Supplement

PROJECT SUMMARY/ABSTRACT:
Amyloid beta (Aβ) is the hallmark of Alzheimer’s disease (AD), but also affect Parkinson disease (PD)
patients, especially in late stages then the dementia (PDD) start to develop. Then PDD advances, about
50% of PDD patients develop very extensive neuropathology similar to AD. It includes misfolded Aβ
plaques and tau neurofibrillary tangles, while the source and scale of Aβ-produced damage, and its effects
on PDD development is unknown. There is also accumulation of insoluble Aβ amyloid around blood vessels
in 53% PD patients called cerebral amyloid angiopathy (CAA). We previously found that systemic Aβ
peptide, generated by blood platelets during cerebral thrombosis, is highly visible on and around the
blood vessels inside the brain. In addition, in murine model of PD then chemicals are injected in the brain
to kill dopaminergic neurons, Aβ appeared on blood vessels walls and around as well. We hypothesized
that tissue accumulation of Aβ and CAA in Parkinson disease may be a result of constant platelet activation
due to local brain inflammation, with high quantities of Aβ transported through blood vessel walls to brain
tissue, injuring it. The objectives of this proposal are to find the platelet-related mechanisms involved in
late PD pathogenesis. Our specific aims will test whether the direct reduction of platelet count, platelet
activation/degranulation, or blood plasma Aβ carriers are important in the development of Aβ
accumulation. Our proposed innovative research will show whether this direct approach is effective and
could thereby lead to a cure for late stage Aβ accumulation in PD. This approach might open the gateway
for new therapeutics to stop the development of PDD, which would be a very significant contribution to
general health.

Public health relevance
PROJECT NARRATIVE: Parkinson’s disease (PD), late PD dementia (PDD) and PD-related amyloid angiopathy are a looming disaster for public health. The combined direct and indirect cost of Parkinson’s, including treatment, social security payments and lost income, is estimated to be nearly $52 billion per year in the United States alone. Near 1 million Americans are living with PD (2020), and the numbers are growing, as there is no definitive cure. The projected research is highly relevant, as proposed control of systemic β-amyloid peptide production and transport involving platelets and blood will inhibit the advance of the late disease dementia, and will open up an avenue for novel therapy.